CTSA K12 Program at The University of Texas Health Science Center at San Antonio

Abstract
Excellent mentorship is critical to the career success of clinical and translational scientists. As such, the
CTSA K12 program is aptly named the Mentored Research Career Development Award Program in Clinical and
Translational Science. K12 Scholars generally have a team of mentors comprised of content experts,
methodologists, and career development advisors. The new CTSA K12 funding opportunity announcement
(PAR-21-336) also requires each Scholar’s mentoring team to include a clinician, and for Scholars planning to
lead or gain experience in clinical trials, a clinical trialist mentor. As with the other components of the CTSA
grant, the K12 also emphasizes diversity, equity, inclusion, and accessibility (DEIA). Evidence-based mentor
training for clinical and translational scientists is available and widely used, including at our University of Texas
Health Science Center at San Antonio (UTHSCSA) CTSA hub, yet no such training exists for non-researcher
clinicians interested in co-mentoring researchers.
The aim of this administrative supplement is to 1) develop, 2) implement, and 3) evaluate a short mentor
training workshop for clinicians and clinical trialists at UTHSCSA and its CTSA partner, UT Austin, and then to
disseminate the training program throughout the CTSA Consortium. Experts in mentorship training from the
University of Wisconsin (UW) and experienced clinician-investigators from our hub will co-develop a mentor
training curriculum for 24-30 clinician/clinical trialist mentors. The anticipated 4-hour curriculum will cover 6
standard core competencies along with elements from the Enhancing Cultural Awareness curriculum and a
newly developed workshop on team mentoring, and will be offered in-person at one study site and virtually at
the other so as to enable comparing modalities. Clinicians completing the mentor training will then be matched
to current K12 Scholars and join their mentorship teams. The clinician mentor will advise the Scholar regarding
feasibility of conducting clinical research projects, translating research findings into clinical practice, and other
matters as they arise. A mixed-methods evaluation will assess the experiences of clinician mentors and K12
Scholars once they have worked together. To sustain the program beyond the grant award period, using their
train-the-trainer model, the UW team will train a UTHSCSA CTSA hub co-investigator to administer the training.
We will disseminate the curriculum through the national KL2/K12 PI Directors Consortium Group; the recently
launched CTSA Mentorship Community of Practice led by UW; conference presentations; and publications.
Although the proposed clinician mentor training is designed to fill the needs of K12 Scholars locally and
nationally, other trainees, such as predoctoral and postdoctoral T32 trainees, and junior faculty conducting CTS
stand to benefit as well.

Public health relevance
Project Narrative The new CTSA K12 funding opportunity announcement (PAR-21-336) requires each K12 Scholar’s mentoring team to include a clinician, and for Scholars planning to lead or gain experience in clinical trials, a clinical trialist mentor. Formal mentor training specifically tailored to non-researcher clinician mentors, however, is not available. In this project, we aim to develop, implement, evaluate, and disseminate mentorship training tailored to clinicians planning to co-mentor researchers.